GAPcare II: The Geriatric Acute & Post-acute Care Coordination Program for Fall Prevention in the Emergency Department

PROJECT SUMMARY
Falls by older adults are often predictable and preventable, yet there is a notable lack of research evaluating
interventions to reduce the occurrence of recurrent falls in older adult Emergency Department (ED) patients.
Dr. Goldberg’s Beeson K76 project GAPcare II, the Geriatric Acute & Post-acute Care Coordination Program
for Fall Prevention in the Emergency Department, addresses this lack of research by further refining and
examining the intervention she created in her GEMSSTAR R03 project. In this intervention, patients,
caregivers, physical therapists (PTs), pharmacy specialists, and clinicians provide a patient-centric,
collaborative approach to fall prevention that bridges the ED visit with outpatient resources. PTs evaluate
geriatric patients in the ED immediately after their fall, perform a focused assessment of future fall risk and
determine the safety of discharge home. Pharmacists in the ED perform a medication therapy management
session aimed at reducing/tapering fall risk increasing medication. ED clinicians, patients and caregivers in
turn incorporate the advice offered by these professionals before the patient leaves the ED.
In her Beeson K76 GAPcare II project, Dr. Goldberg will build on the lessons learned from the GEMSSTAR
R03 work. GAPcare II’s specific aims are to: (1) conduct field testing with geriatric patients with and without
cognitive impairment and their caregivers to assess the feasibility, acceptability, and usability of the Apple
Watch to objectively measure fall-related outcomes; (2) refine the GAPcare intervention and study protocol
based on lessons learned and findings from the GEMSSTAR R03 GAPcare I pilot study and conduct a small
open trial of the GAPcare II intervention; and (3) conduct a pilot randomized, controlled trial (RCT) of the
GAPcare II (n=200) intervention to obtain initial estimates of efficacy of GAPcare II to decrease recurrent falls
at 12 months relative to usual care. This investigation will provide Dr. Goldberg with critical pilot data and
expertise to submit a R01 proposal to NIA for a full-scale, multi-center, comprehensive RCT.
Dr. Goldberg’s Beeson K76 award overarching aims are to develop and test an ED-based and post-discharge
protocol that reduces recurrent falls in older adults and to launch her physician-scientist career as an emerging
leader in geriatric emergency medicine. To achieve this goal, Dr. Goldberg will obtain additional training in
qualitative research, digital health, longitudinal data analysis, clinical trial methods, and leadership. This
expertise will be achieved through advanced coursework, leadership training, and intensive interactions with
her mentorship team. Her primary mentors, Dr. Roland Merchant, emergency medicine physician and
epidemiologist, and Dr. Vincent Mor, health services researcher and health policy expert, will provide training
in epidemiology, health services research, and leading policy initiatives. Her mentorship team also includes
experts in qualitative research, digital health, rehabilitation measures, longitudinal data analysis, clinical trial
methods, fall prevention and geriatric medication management.

Public health relevance
PROJECT NARRATIVE The public health significance of GAPcare II is immense as it proposes a multidisciplinary care coordination program that addresses the Healthy People 2020 goals of preventing and reducing injuries and enhancing life independence among older adults. This project is directly responsive to NIA’s “Strategic Directions for Research on Aging”, section B5: Identify, analyze, and track changing patterns of disability and mortality for older adults and better understand factors contributing to these patterns. Dr. Goldberg’s technology-assisted fall prevention intervention could provide a model of care to reduce subsequent falls in high-risk emergency department seniors and supports the further training of Dr. Goldberg to become a leader in geriatric emergency care.